Molecular and circuit mechanisms of nausea-associated behaviors

Project summary
Nausea is an unpleasant sensation of visceral malaise often accompanied by an involuntary urge to vomit.
Nausea responses to toxin ingestion and infection are evolutionarily beneficial survival behaviors that
avoid or expel toxins which may cause peripheral tissue damage. However, the sensation of nausea can
also be maladaptive, as many treatments for cancer, diabetes, and other illnesses induce nausea as a
major side effect, while current anti-emetic drugs have only limited efficacy. Known as the
“chemoreceptors trigger zone” for nausea, the area postrema is a brain circumventricular sensory organ
critical for nausea and vomiting. Neurons in the area postrema occupy a unique anatomical location with
a deficient blood-brain barrier, and can be regulated by inputs from both the humoral routes and the
gastrointestinal tract. However, little is known about how area postrema neurons contribute to the
mechanisms of nausea and its related aversive behaviors. Using single-nucleus RNA-sequencing
combined with genetic and behavioral studies, we have recently discovered a population of the area
postrema neurons that, in response to emetic cues, induce nausea-associated aversive behaviors in
mice. Here, I propose a multi-tiered approach, based on these preliminary findings, to investigate the
humoral and vagal inputs to the chemosensory circuit of the area postrema and how they contribute to
nausea. First, I will identify humoral cues that act through the area postrema aversion-promoting
excitatory neuron types by testing a panel of nausea-inducing or anorexigenic humoral stimuli (Aim 1).
Next, I will map and identify vagal inputs to the genetically defined area postrema excitatory neuron types
using viral tracing and channelrhodopsin-assisted circuit mapping techniques (Aim 2). These
experiments will reveal how vagal inputs and humoral cues can regulate the functions of the area
postrema neurons which mediate nausea-associated aversive behaviors. Following this training, I will be
poised to transition to the R00 phase of my career and establish a unique independent research program
incorporating targeted cell-type manipulation in vomiting animal models (Aim 3). These studies will
elucidate the cellular and neural mechanisms nausea and may guide the design of novel anti-emetic
therapies. Central to this proposal is the mentorship of Dr. Stephen Liberles, an expert in internal
sensations, Dr. Brad Lowell, an expert in functional circuit mapping, Dr. Frank Reimann, an expert in gut
hormone signaling, Dr. Chenghua Gu, a leader in blood-brain barrier mechanisms, and Dr. Charles Horn,
an expert in vomiting models and nausea physiology. They will provide career guidance and help me
achieve my training goals. In my application I have outlined a comprehensive plan for acquiring the
conceptual, technical, and professional skills that will enable my transition to an independent research
position.

Public health relevance
Project Narrative The area postrema, a brain circumventricular sensory organ regulated by both humoral signals and inputs from the gastrointestinal tract, plays a critical role in nausea and aversive behaviors. During my postdoctoral fellowship, I identified and characterized a population of area postrema neurons which mediates aversive behaviors, and here I will specify and map both humoral and vagal inputs to these area postrema neurons and understand their physiological effects. Acquiring expertise required to achieve these aims, namely hormone signaling and functional circuit mapping, will enable me to establish an independent research program which focuses on the cellular and neural mechanisms of nausea combining mice and vomiting animals, and may lead to the development of novel anti-emetic therapies.